CEREBRAL AUTOREGULATION MONITORING TO REDUCE BRAIN INJURY FROM CARDIAC SURGERY

DESCRIPTION (provided by applicant): Brain injury during cardiac surgery results primarily from cerebral embolism and/or reduced cerebral blood flow (CBF). The latter is of particular concern for the growing number of surgical patients who are aged and/or who have cerebral vascular disease. Normally, CBF is physiologically autoregulated (or kept constant) within a range of blood pressures, allowing for stable cerebral O2 supply commensurate with metabolic demands. Cerebral autoregulation is impaired in patients who are undergoing cardiac surgery and have cerebral vascular disease or many other conditions. Such impairment could lead to brain injury because current practices of targeting low mean arterial blood pressure empirically (usually 50-70 mmHg) during cardiopulmonary bypass (CPB) may expose patients with impaired cerebral autoregulation to cerebral hypoperfusion. The hypothesis of this study is that targeting mean arterial pressure during CPB to a level above an individual's lower autoregulatory threshold reduces the risk for early neurologic complications from cardiac surgery or postoperative cognitive decline. Cerebral autoregulation will be monitored in real time by using software that continuously compares the relation between arterial blood pressure and low-frequency changes in transcranial Doppler measured cerebral blood flow velocity as well as cerebral oximetry measured with near infrared spectroscopy using methods we have validated. The primary endpoint of the study will be a composite outcome of clinical stroke, and/or new ischemic brain lesions detected with diffusion-weighted magnetic resonance (MR) imaging, and/or cognitive decline from baseline at 4 to 6 weeks after surgery. We will further assess for a relationship between blood pressure below the limits of autoregulation and delirium, an end-point associated with morbidity and mortality. Brain injury from cardiac surgery is an important source of operative mortality, prolonged hospitalization, increased healthcare expenditure, and impaired quality of life. Developing strategies to reduce the burden of this complication has wide public health implications and is within the mission of the NHLBI.

Public health relevance
PUBLIC HEALTH RELEVANCE: Neurological complications from cardiac surgery are an important source of operative mortality, prolonged hospitalization, healthcare expenditure, and impaired quality of life. New strategies of care are needed to avoid rising complications for the growing number of aged patients undergoing cardiac surgery. This study will evaluate novel techniques that could be widely used to reduce brain injury that results from inadequate brain blood flow during surgery.